Identification of Wildlife and Domestic Animal Bacterial Pathogens in Wyoming

IDENTIFICATION OF WILDLIFE AND DOMESTIC ANIMAL BACTERIAL PATHOGENS IN
WYOMING
PROJECT SUMMARY/ABSTRACT
The Wyoming State Veterinary Laboratory (WSVL) is based within the Department of Veterinary
Sciences at the University of Wyoming. The WSVL mission is to promote animal and human
health in the region through diagnostic medicine and disease surveillance. The WSVL is
accredited by the American Association of Veterinary Laboratory Diagnosticians (AAVLD) and
maintains capabilities in pathology, serology, parasitology, virology, bacteriology, and
sequencing. As an AAVLD-accredited laboratory, WSVL ensures results are accurate,
reproducible, and timely. Bacterial isolation, identification, and antimicrobial susceptibility testing
(AST) from clinical and autopsy samples are vital services provided by the WSVL bacteriology
section. This proposal aims to further build capacity in this important area to promote human and
animal health. Specifically, we will, 1. improve matrix-assisted laser desorption ionization-time of
flight mass spectrometry (MALDI-TOF MS) identification of bacterial organisms from mammals
and fish that cannot currently be identified to the species-level, 2. Combine AST and genomic
sequencing on isolates to fully characterize resistant strains and genes. The WSVL is currently
building capacity to enhance its diagnostic capabilities for both domestic animal and wildlife
testing. Association of phenotypic and genotypic profiles will support a better understanding of
antimicrobial resistance (AMR) mechanisms in fish pathogens given the lack of clinical
breakpoints and laboratory standards for performing AST in aquatic species. The research will
significantly improve capacity at the WSVL. Specific goals include expanding bacterial whole
genome (WGS) sequencing capacity, developing a custom MALDI-TOF MS reference library for
wildlife and domestic animal pathogens to improve species level identification of bacterial
organisms from clinical samples, and AMR genomic surveillance. Furthermore, with the capacity
to perform WGS on bacterial pathogens, the WSVL will be well positioned to participate in the
Veterinary Laboratory Investigation and Response Network AMR monitoring programs.

Public health relevance
NARRATIVE The Wyoming State Veterinary Laboratory (WSVL) provides testing for diseases affecting domestic and wildlife animals in Wyoming and the region and receives diagnostic specimens daily for laboratory testing. The WSVL is currently building capacity to expand diagnostic testing for fish species (Aeromonas, Acinetobacter), as well as for a wide variety of Mycoplasma, Actinobacillus and Streptococcus species, to accurately identify these pathogens associated with diseases in domestic and wildlife animals. Expanding diagnostic capabilities for species-level identification will improve public health surveillance and control of zoonotic diseases; and by identifying and monitoring these pathogens, the project will contribute to preventing outbreaks and safeguarding animal and human health in Wyoming and beyond.